Epigenetics and choline: mediation of fetal alcohol effects in a rat model

DESCRIPTION (provided by applicant): The proposed training is designed to provide the candidate with a background in animal cognition and testing as well as training in molecular mechanisms of development. The candidate is a well-trained developmental cognitive neuroscientist with a dedication to at-risk children. However, human research is limiting in that mechanisms cannot be established due to the lack of available tissue. The training proposed in this application will facilitate the candidate's pursuit of her long-term goal of being able to ask scientific questions by moving from the clinic to the bench and back again. Specifically, the candidate will work on the mechanisms involved in the effects of fetal alcohol exposure. This preventable, highly prevalent developmental phenomenon is characterized by a constellation of adverse outcomes including neurodevelopmental abnormalities, growth retardation, and facial structure anomalies. Scientists working with animal models have provided evidence that choline supplementation given concomitant with or after fetal alcohol exposure mediates the effects. The proposed research will establish the mechanisms involved in this mediation by describing any epigenetic modifications and will extend previous research by testing choline as a preventative measure, giving it before and during alcohol exposure in a rat model. In Experiment 1, the candidate will develop a novel choline-supplemented liquid diet for the rats. This diet will be important in the avoidance of the stress of injections that is inherent in cholin administration. The goal of Experiment 1 is to determine if the taste of choline will deter the rat from consuming as much ethanol as the ethanol-only group. If so, subcutaneous injections of choline and vehicle will be necessary. In Experiment 2, pregnant rats will be divided into 3 experimental groups: ethanol-exposed, choline-supplemented, and ethanol-exposed with choline supplementation. Each experimental group will have a matching control group, and an unhandled pellet fed control will be included for a total of 7 diet groups. One male pup from each litter (n=10) will comprise groups for analyses. Hippocampal slices, blood DNA, and brain DNA will be collected on GD 18 (after cell proliferation in hippocampus), PD 45 (prior to Morris water maze training), and PD 54 (after Morris water maze training). Hippocampal slices and blood will be assessed with bisulfite pyrosequencing (epigenetics) and real-time RT-PCR (gene expression) for a selection of genes related to hippocampal development, choline, and alcohol metabolism. Protein levels will be assessed by immunolabeling of frozen brain sections. The research will be completed with a mentoring team comprised of top experts in the field: Steven Zeisel (choline and epigenetics), Jennifer Thomas (animal models of fetal alcohol exposure and mediation of same with choline), and Phillip May (sequelae of fetal alcohol effects in humans). The candidate and two of the mentors are on the faculty of the University of North Carolina at Chapel Hill Nutrition Research Institute (NRI) on the new North Carolina Research Campus in Kannapolis, North Carolina. Having only opened in 2008, this campus is outfitted with state-of-the-art facilities. Laboratories in the NRI are equipped with the newest of DNA sequencing, genotyping, and gene expression equipment. The David H Murdock Research Institute (DHMRI) provides over 110,000 square feet of instrumentation, resident expertise, and well-equipped -omics laboratories. In addition, the DHMRI maintains a 40,000 square foot vivarium with top-of-the-line equipment. All equipment needed for this project is available on this campus; many scientists are housed here and are available to provide expert support to the candidate. The results of these studies will inform an R01 application (candidate's short-term goal) in which the candidate will propose an intervention to determine the effects of choline supplementation in human fetuses who are at risk for fetal alcohol exposure. This work is integral to the understanding of the fetal alcohol exposure phenotype and will be the initial steps toward the use of a nutrient - choline - to mediate or even prevent the effects of fetal alcohol. The candidat has demonstrated her commitment to at-risk children. The proposed training will provide her with a deeper understanding of the mechanisms involved in developmental phenomenon thereby strengthening her ability to form and test hypotheses. As a result of being able to move between the clinic and the bench, the candidate will build a strong, independent research program.

Public health relevance
PUBLIC HEALTH RELEVANCE: The project will explicate the mechanisms involved in the mediation of fetal alcohol effects by choline supplementation in rats. Epigenetic modifications and hippocampal dysfunction will be explored. The results will be the basis for a clinical trial in which choline will be tested for its ability to prevent fetal alcohol effects in at-risk infants. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Fetal alcohol spectrum disorders (FASD) refer to a constellation of adverse outcomes including neurodevelopmental abnormalities, growth retardation, and structure anomalies. Despite warnings of the effects of alcohol on the fetus, FASD are estimated to effect as many as 2 - 5% of the children in the United States (May & Gossage, 2001; May et al., 2009; Sampson et al., 1997). As with any developmental phenomenon, the degree to which the developing fetus is affected depends on the timing, dose, and duration of the insult (Cheatham, Sesma, & Georgieff, 2010), and as a result, the level of dysfunction and abnormalities can vary greatly. Thus, a wide range of dysfunction falls under the non-diagnostic umbrella of FASD (Sokol, Delaney-Black, & Nordstrom, 2003). The sequelae differ along this spectrum, but the common thread is an unmistakable adverse effect on the cognitive abilities subserved by the hippocampus (bilateral, temporally- located brain structures - memory processing), and the frontal lobes (executive functions such as planning, cognitive flexibility, working memory, and inhibitory control)(Mattson, et al., 2010). Work with animal models supports our hypothesis that the cognitive dysfunction evidenced in FAE is the result, in part, of disruption in neurogenesis in the dentate gyrus. We further hypothesize that this disruption can be related to epigenetic changes during gestation as research with choline, an important element in epigenetic modification, shows that it can mitigate the effects of fetal alcohol exposure (FAE). The overall objective of the proposed studies is to establish the utility of choline as a prophylactic against the effects of FAE and to describe biomarkers in a rat model related to rat brain that will enable assumptions about the epigenome of the human brain. The long- term goal is to utilize the knowledge gained here in support of a clinical trial R01 in which we will explore the utility of choline supplementation in the development of human fetuses at risk for alcohol exposure effects. As the cognitive dysfunction related to FAE is pervasive, it is imperative that interventions be designed and implemented. To accomplish our overall objective, we will test the following specific aims: Specific Aim 1: To develop a choline supplemented liquid ethanol diet. In an effort to avoid the stress of subcutaneous injections of choline and better model oral administration in humans, we will develop a novel choline-supplemented liquid diet to which we will add ethanol. If the volume of ethanol consumed is not affected by the addition of choline, Experiment 2 will be conducted using all liquid diets. If the addition of choline to the liquid diet alters consumption, choline supplementation in subsequent studies will be by subcutaneous injection. Specific Aim 2: To determine that choline supplementation will prevent the cognitive deficits of fetal alcohol exposure. Under the mentorship of Jennifer Thomas and the other members of my mentoring team, I will develop a rat model of chronic FASD that compromises the hippocampus. Previous research has shown that choline administration after or concomitant with alcohol exposure mitigates the effects of fetal alcohol exposure. We will test the hypothesis that choline supplementation administered continuously before and during alcohol exposure will prevent the effects of FAE. Dams will be supplemented with choline before mating and throughout gestation. It is hypothesized that offspring of rats fed a liquid diet that includes 35% alcohol-derived calories from GD5-20 will exhibit hippocampal dysfunction as measured on a spatial navigation task, relative to a pair-fed and an unhandled control group, and that choline supplementation will prevent this dysfunction. Specific Aim 3: To ascertain the epigenetic effects of choline supplementation in the rat model of chronic fetal alcohol exposure. It has been proposed that epigenetic modifications may be the mechanism for the sequelae found in FAE (Zeisel, 2011). Under the mentorship of Steven Zeisel and the other members of my team and in consultation with Mihai Niculescu, I will test the hypothesis that fetal alcohol exposure exacts changes in neurogenesis in the fetal hippocampus and disrupts hippocampal plasticity that typically corresponds with learning postnatally. In addition, it is hypothesized that choline supplemented groups will show different patterns of epigenetic change relative to ethanol groups (see Aim 4). A panel of candidate genes will be assessed for epigenetic modifications at three timepoints: during gestation, before cognitive training, and after cognitive training. If a gene exhibits epigenetic change, we will determine through gene expression the direction of that change (was gene turned up or down) and the resulting protein expression in the hippocampal areas of interest. Specific Aim 4: To identify an epigenetic biomarker of prenatal alcohol exposure in rat that can be related to human and used as a proxy for gene expression in human brain. Because it is not possible to directly assess gene expression in the brains of acting humans, we will establish the relation between epigenetic information in blood DNA and brain in rat under the assumption that we will then be able to infer human brain from human blood. Blood DNA and hippocampal tissue will be analyzed by pyrosequencing and the results compared for commonalities.